Molecular control of tolerogenic dendritic cell function

PROJECT SUMMARY/ABSTRACT
Dendritic cells (DCs) are the key sentinel cells of the immune system that directly recognize pathogens and
initiate adaptive T and B cell responses. In addition to their essential role in antimicrobial and antitumor
immunity, DCs are thought to control immune homeostasis and promote tolerance. Conversely, aberrant
antigen presentation and/or cytokine production by DCs have been implicated in nearly every autoimmune
disease. However, the role and mechanism of the tolerogenic function of DCs are poorly understood. In
particular, the control of the "switch" between the tolerogenic and immunogenic DC function and the molecular
programs underlying these functions remain largely unknown. Our preliminary studies have identified a
potential molecular regulator of tolerogenic DCs, whose deletion impairs DC function and leads to the loss of
T cell tolerance. The proposed project will seek to pinpoint the DC subset responsible for this phenotype (Aim
1) and characterize its molecular basis, including aberrant cytokine production (Aim 2) and impaired signaling
(Aim 3). Collectively, these studies would help delineate the molecular control of tolerogenic DCs and provide
insights into the mechanisms of DC-mediated peripheral tolerance.

Public health relevance
PROJECT NARRATIVE The loss of immune tolerance underlies the development of autoimmune diseases, many of which (such as multiple sclerosis and systemic lupus erythematosus) represent major unmet medical needs. Dendritic cells are thought to maintain tolerance and prevent the development of autoimmune disease in normal conditions. The proposed work will explore the mechanisms whereby dendritic cells perform this "tolerogenic" function and thus may have implications for the pathogenesis of autoimmune diseases.